Admin Core

PROJECT SUMMARY / ABSTRACT The Minnesota Department of Agriculture (MDA) Laboratory Services Division (LSD) is seeking funding under FDA funding opportunity PAR-20-105, “Laboratory Flexible Funding Model (U19)? The MDA laboratory is applying for Discipline A: Microbiology (Analytical Track 1: Food Defense, Analytical Track 2: Food Product Testing, Analytical Track 3: Animal Food Product Testing and Analytical Track 5: Microbiology Capability/Capacity Development), Discipline B: Chemistry (Analytical Track 1: Food Defense, Analytical Track 2: Human Food Product Testing, Analytical Track 3: Animal Food Product Testing and Analytical Track 4: Chemistry Capability/Capacity Development) and Discipline D: Special Projects (Analytical Track 1: Sample Collection and Analytical Track 3: Method Development and Validation). In the research strategy the laboratory outlines the plan and strategy for the overall administration, management and coordination of the projects. Project Summary/Abstract - Minnesota Department of Agriculture